Solving the puzzle of beta-1,6-glucan in the cryptococcal cell wall

Solving the puzzle of beta-1,6-glucan in the cryptococcal cell wall
ABSTRACT
Cryptococcus neoformans is a global pathogen responsible for roughly 150,000 deaths each year, mainly in
HIV+ individuals but with increasing morbidity in non-AIDS patient populations. Like other fungi, C. neoformans
is bounded by a complex and resilient cell wall, which maintains cell integrity while allowing morphologic flexibility.
Wall synthesis is a compelling research area, because it is a validated target of antifungal drugs. Unfortunately,
these do not work against C. neoformans infection, revealing a pressing need to elucidate the biosynthesis - and
potential vulnerabilities - of the cryptococcal wall.
Our long-term goal is to define cell wall biosynthesis in C. neoformans, to deepen our understanding of this
critical process and potentially identify targets for antifungal therapy. Much of the wall is composed of various
polymers of glucose, or glucans, which differ in their linkage and branching patterns. Our focus here is on β-1,6-
glucan, which is a key component of cell walls because it helps interconnect other wall components but whose
synthesis is poorly understood. This material is particularly abundant in C. neoformans, even though the crypto-
coccal genome does not encode homologs of several proteins that have been implicated in its synthesis in other
yeast. We have discovered that cryptococcal cells lacking a putative glycosyltransferase called Ggt2 are dra-
matically impaired in wall β-1,6-glucan, cell integrity, and virulence. Based on our preliminary results and struc-
tural features of this protein, we hypothesize that Ggt2 acts directly in the formation of β-1,6-glucan.
To pursue our promising initial findings, we propose to determine how Ggt2 affects cryptococcal wall structure,
its cellular role, and its biochemical activity. We further propose to identify the C. neoformans machinery required
for β-1,6-glucan synthesis. We plan to achieve these goals by pursuing three aims in parallel: Aim 1 is to combine
biochemical and biophysical methods to define the cell wall of wild-type and ggt2∆ cells. Aim 2 is to establish
the biochemical function of Ggt2 and its role in cell wall synthesis. Aim 3 is to apply genetic strategies to discover
proteins that either participate in β-1,6-glucan synthesis or compensate for its loss, and to initiate mechanistic
studies of these candidates.
We propose highly feasible studies in pursuit of aims that are designed to be independent yet complementary.
Our results will increase fundamental understanding of the cryptococcal wall and processes that are crucial for
its integrity, and possibly open the way to new therapeutic strategies. Achieving our aims will also leave us poised
for exciting future studies, including further structural studies of fungal walls, potential screens for inhibitors of
Ggt2, and mechanistic dissection of β-1,6-glucan synthesis with potential application to other fungi.

Public health relevance
PROJECT RELEVANCE / NARRATIVE This research is highly relevant to public health because the organism under study causes serious human illness for which current therapies are not adequate. Fungal cell walls are a validated target for antifungal therapy, but unfortunately these drugs are not effective against Cryptococcus. Our studies will focus on one poorly under- stood component of the cell wall that is particularly abundant in this pathogen, to elucidate critical basic biology and potentially expose vulnerabilities that may be exploited.